RP1 _NBEC

Clinical evidence of persistent, large, and increasing mortality gaps between Non-Hispanic Black and other
women in the United States, along with patient surveys and personal stories leave no doubt that implicit bias
and racism in the health care system contribute significantly to disparate maternal outcomes. Central to
identifying the factors to reduce maternal mortality are interventions for healthcare providers and institutions to
recognize the root causes of racism and bias. Our long-term goal is to make respectful care practices the
standard across the care continuum—pre-conception to 1-year postpartum—to reduce disparities in maternal
outcomes. The overall objective for this application, which is the next step toward attainment in our long-term
goal, is to demonstrate a multifaceted, evidence-based intervention will reduce hospital disparities in maternal
outcomes. Our central hypothesis is that hospitals that implement the multifaceted intervention of training,
incorporating equity in all quality improvement efforts, and partnership building with community-based
organizations will have better maternal health outcomes than hospitals who have implemented remote
asynchronous implicit bias training alone. Our previous studies connect mistreatment, discrimination, and
racism across the care continuum to physical and emotional harm to Black mothers. The rationale that
underlies the proposed research is that reducing inequitable and disrespectful treatment is likely to offer strong
scientific rationale for taking a multifaceted approach to equity work to reduce disparities. Our research
strategy will be to conduct a multi-hospital cluster-randomized controlled trial within 9 Ochsner hospitals
(~1900 staff and 14000 deliveries per year) to compare an interactive multifaceted intervention—implicit bias
training, incorporating equity in all quality improvement, and community partnership building— to a remote
asynchronous training alone intervention. Maternal health will be measured by a composite outcome matched
to ACOG patient safety bundle recommendations, collected centrally through electronic health records, and
patient satisfaction by Hospital Consumer Assessment of Healthcare Providers and Systems routinely
collected data. This will enable us to achieve the following Aims: 1) Determine the effect of a multifaceted
respectful maternity care intervention on hospital maternal outcome and patient satisfaction disparities; 2)
Determine the effect of a multifaceted respectful maternity care intervention on provider bias; 3) Examine how
a respectful maternity care and implicit bias intervention among impacts patient and hospital staff satisfaction.
These results are expected to have an important positive impact because they will provide strong evidence-
based proof of principle that, by bringing together existing approaches for addressing biased treatment and
care, maternal outcome disparities are reduced.